Neurodegenerative reprograming of microglia in Alzheimer’s disease

ABSTRACT
Genetic studies implicate microglia—the brain's primary innate immune cells—as major determinants for the
risk of Alzheimer's Disease (AD). In murine AD models, microglia can assume phenotypes with protective or
neurodegenerative functions, such as driving aberrant synapse loss. This proposal aims to elucidate molecular
mechanisms that identify and give rise to functionally neurodegenerative microglia—a critical knowledge gap in
the field. The results may inform future therapeutic avenues in the treatment of AD via the elimination of these
microglia.
Ultrastructural studies in humans and mice discovered a subset of “dark” microglia, characterized by signs of
cellular stress, prominent chromatin compaction, and frequent contact with synaptic elements in conditions of
pathological synapse loss. This grant is based on the premise of these studies, which attributed a
neurodegenerative role to microglia with cellular stress. We recently discovered that a conserved stress
signaling pathway, the integrated stress response (ISR), is activated in dark microglia. Using two novel mouse
models that allow us to turn on or off ISR cell-autonomously in microglia, we showed that ISR is sufficient to
generate the dark microglia phenotype in the absence of external stimuli. In murine amyloid and tau models of
AD, inducing ISR in microglia worsened their neurodegenerative impact while inhibiting ISR ameliorated them.
ISR can result from exposure to diverse genetic (e.g., APOE4 allele) and non-genetic (e.g., aging) risk factors
for AD. Therefore, the driving hypothesis is that ISR—triggered by risk factors—serves as an upstream event
that epigenetically reprograms microglia, exacerbating their stressed phenotype upon exposure to amyloid
pathology and worsening neurodegeneration. To address this hypothesis, we will first determine the
mechanisms of ISR-induced chromatin remodeling. Second, we will test whether ISR exacerbates the stressed
phenotypes of microglia in amyloidosis models. Third, we will test if ISR worsens the neurodegenerative impact
of microglia in amyloidosis and tau models.
The proposed framework provides conceptual innovation to the field of AD by focusing on interlinked cellular
stress and epigenetic mechanisms in the neurodegenerative reprogramming of the brain's resident immune
cells. Mechanistic deconstruction of this process is possible due to our technically innovative approaches that
combine novel mouse models with advanced molecular techniques and by leveraging biotechnological tools
and expertise available at the state-of-the-art core facilities at CUNY Advanced Science Research Center and
other New York institutes, as well as our productive collaboration with co-PI Dr. Marie-Ève Tremblay.

Public health relevance
NARRATIVE Microglia, the brain's primary immune cells, play a major role in influencing the risk of Alzheimer's disease, which is highly prevalent but lacks effective treatment. This research examines how microglia transform through epigenetics over the lifespan and whether this transformation triggers the development of Alzheimer's disease by creatively using novel mouse models and other biotechnological tools. The results will provide a mechanistic insight into the development of Alzheimer's disease that may inform novel therapeutic avenues.